Unraveling the earliest phases of vascular cognitive impairment and dementia using CADASIL--a monogenic form of small vessel cerebrovascular disease

Project Summary/Abstract
The project addresses vascular contributions to cognitive impairment and dementia (VCID) using a design that
exploits the enrollment of persons with the autosomal dominant gene for Cerebral Autosomal Dominant
Arteriopathy with Subcortical Infarcts and Leukoencephalopathy (CADASIL). Exploration of VCID by
focusing on the rare heritable monogenic disorder, CADASIL, will advance knowledge of the full spectrum of
vascular dementia from presymptomatic gene carriers through dementia and will facilitate an examination of
mixed dementia in CADASIL participants also having AD. This research is novel from any other in its efforts to
study a single-gene vascular dementia group throughout the life span in an effort to reduce vascular dementia
heterogeneities selecting persons enriched for certain future vascular disease secondary to NOTCH3 gene
mutation. CADASIL is caused by a mutation in the gene NOTCH3, which encodes a receptor protein. Although
rare, CADASIL is the most common heritable cause (due to a single gene mutation) of vascular dementia.
Many consider CADASIL to be a good single gene model of small vessel disease and vascular dementia. By
improving our understanding of CADASIL and its progression, we will be better able to understand VCID as
well as mixed dementias having both CADASIL and the most common sporadic dementia, Alzheimer's
disease. This is particularly important because of the fact that many cases of Alzheimer's disease have co-
occurring vascular dementia. More than 200 genetic variations in NOTCH3 have been identified, but it is not
known which cause milder, or more severe, forms of VCID. Furthermore, among the NOTCH3 mutations
known to cause CADASIL, and even within CADASIL families, there is wide variability in age at onset, disease
progression, brain imaging abnormalities and presentation of symptoms. Some recent data reported by the
CADASIL European Consortium suggests that patients with mutations in certain parts of NOTCH3 cause a
more severe form of CADASIL than do mutations in other parts of the gene. It's also likely that variations in
other genes influence the effect of NOTCH3 mutations on VCID. Unfortunately, no large cohort of CADASIL
patients for clinical research has been organized in North America. Better understanding of the associations
between clinical presentation, potential disease modifiers (i.e., risk factors) and NOTCH3, as well as other
gene variations in a new cohort in the United States could improve understanding of the causes and severity
contributions to various forms of small-vessel disease and vascular dementia. To accomplish this, we will
recruit, characterize and follow longitudinally a cohort of 400 NOTCH3 variant/mutation carriers, plus 100 non-
carriers as controls, from U.S. CADASIL families. Participants will be evaluated every 18 months with detailed
neurological, cognitive, behavioral, functional, blood, genetic and brain MRI assessments. This study will
provide critical information regarding CADASIL that will also advance understanding for the most common type
of mixed dementias (viz., VCID and AD).

Public health relevance
Project Narrative: This research project aims to better understand vascular contributions to cognitive impairment and dementia (VCID) by studying CADASIL, the most common heritable cause of vascular dementia. Propensity for Alzheimer's disease will be assessed in each CADASIL research participant facilitating exploration of mixed dementia.